Kinetic Mechanisms of Chromatin Remodeling and Transcription

Project Summary
Advances in eukaryotic gene expression have provided a comprehensive list of transcription-related proteins,
their biochemical activities and structure-function relationships, and revealed the importance of histone
modifications and nucleosome remodeling enzymes that cooperate with sequence-specific DNA binding
transcription factors, resulting in a transcriptionally poised chromatin architecture at gene promoters and
enhancers. However, major challenges remain in the lack of knowledge of the timescales and kinetics by which
epigenetic and transcription proteins operate on chromatin substrates. This proposal will address these
challenges by focusing on quantitative kinetics of chromatin remodeling and transcription, using state-of-the-art
single-molecule imaging techniques applied to living cells and immobilized chromatin templates in vitro,
combined with traditional biochemistry and yeast molecular genetics. Anticipated findings are the identification
of key reaction intermediates, order of events, and rate-limiting steps that will dramatically advance basic,
mechanistic understanding of transcription on native chromatin with high impact on other areas of eukaryotic
DNA metabolism.

Public health relevance
Narrative To integrate chromatin remodeling and histone modifying events with the complex orchestration of transcription enzymology and reveal timescales and kinetics by which epigenetic and transcription proteins operate on chromatin substrates, this proposal aims to use using state-of-the-art single-molecule imaging techniques, biochemistry and molecular genetics, to identify key reaction intermediates, order of events, and rate-limiting steps that will advance basic, mechanistic understanding of genome expression control with high impact on other areas of eukaryotic DNA metabolism.